San Diego Digestive Diseases Research Center

Summary
The overall mission of the San Diego Digestive Diseases Research Center (SDDRC) is to support basic,
translational and clinical research that will lead to improved treatment and prevention of important inflammatory
diseases of the gastrointestinal tract and liver. The foundation of our research efforts lies in a distinct group of
academic investigators, carefully selected for Center membership based on the alignment of their work with the
Center theme of "Inflammation in the Digestive Tract". The SDDRC provides Core services to the research
groups of its members located at three adjacent research institutions in the San Diego area that foster
research productivity and new research directions, and encourage productive collaborations. In addition, the
SDDRC enhances new digestive diseases research through Pilot/Feasibility and Enrichment programs. The
research base includes 45 outstanding and diverse investigators with current digestive diseases-relevant
funding of $22,479,419 in total annual direct costs, of which $7,722,286 (34.4%) are from NIDDK. Since the
SDDRC was originally funded by the NIH/NIDDK as Silvio O. Conte Center in 2019, the Center has
experienced remarkable success. Over the past four years, 95% of all Center members have utilized Core
services. The Center's exceptional productivity and impact are evident in the publication of 274 papers that are
100% compliant with NIH public access policy and acknowledge the Center grant in the publications based
upon usage of SDDRC Core services. Collaboration among SDDRC members has played a pivotal role in
driving this success, with ~50% of publications resulting from joint and collaborative projects between Center
members. The Pilot/Feasibility program has supported 20 diverse and predominantly early-career
investigators, who achieved an impressive success rate of ~80% in securing subsequent funding. Educational
and training events organized by the Enrichment Core have been popular and well-received, as demonstrated
by consistently high attendance rates and positive feedback. Building on these accomplishments, the SDDRC
will continue to offer services to Center members through its three interrelated Biomedical Research Cores.
The Human Translational Core leverages clinical and translational research expertise to offer access to human
biospecimens, and provide consultation in biostatistics and histopathology. The Preclinical Models Core
facilitates and assists in phenotyping and understanding of gastrointestinal and liver diseases using
conventional and gnotobiotic murine models. The Microbiomics and Functional Genomics Core provides
cutting-edge and cost-effective access to sequencing-based technologies and bioinformatic analysis. An
Administrative Core supports the Center administratively and coordinates the Pilot/Feasibility and Enrichment
programs. By creating a unique environment to nurture novel research ideas and interactions, the SDDRC is
exceptionally well-positioned to integrate clinical and bench research to advance the basic understanding of
digestive diseases, and enhance the health and care of patients suffering from those diseases.

Public health relevance
Narrative The San Diego Digestive Diseases Research Center (SDDRC) provides resources and infrastructure that bring together basic and clinical investigators as a means to enhance communication, collaboration and effectiveness in support of their research related to gastrointestinal and liver diseases. It also facilitates new research and the development of early-career investigators focused on digestive diseases.